Development of a stable mRNA prophylactic vaccine against SARS-CoV-2 omicron variant

ABSTRACT
Infectious disease remains one of the leading causes of illness and mortality worldwide. The recent coronavirus
disease 2019 (COVID-19) pandemic caused by severe acute respiratory syndrome coronavirus 2 (SARS-CoV-
2) led to widespread illness and death, disrupting public health and economy. It has been successfully mitigated
thanks to the development and global application of the novel messenger RNA (mRNA) vaccine technology.
While mRNA vaccines have offered significant protection, the high mutation rate of SARS-CoV-2 necessitates
ongoing development of updated vaccines to combat new variants. While mRNA vaccines have shown
remarkable effectiveness against COVID-19 by stimulating both humoral and cellular immune responses, the
main limitation lies in the inherent instability of mRNAs at normal conditions without protection. Therefore, current
mRNA and mRNA formulations require ultralow temperatures for storage and transportation.
Recognizing the instability challenge, we proposed to develop a novel “RNA-plex” technology, which uses an
“carrier-base” polymer to bind to mRNA molecules, preventing them from degradation in fridge or room
temperature during storage. It significantly reduces the transportation and distribution costs, and makes mRNA
vaccines more accessible globally, especially in areas with limited cold chain facilities. Notably, this mRNA
protection technology can universally shield various mRNAs, is compatible with multiple delivery systems, and
significantly enhances mRNA translation in cells, suggesting its promising potential for diverse therapeutic and
research applications.
In this proposal, we will apply this mRNA stabilization technology named “RNA-plex” in the development of stable
and efficient vaccines for SARS-CoV-2 prevention. Specifically, we will optimize the composition and formulation
of RNA-plex to maximize its protective efficacy for SARS-CoV-2 omicron variant spike protein mRNA. Next, we
will apply it in preparing prophylactic lipid nanoparticle (LNP) mRNA vaccines with high stability, enhanced
antigen translation efficiency, and superior vaccination effectiveness compared to conventional approaches
against emerging viral threats, using the recent SARS-CoV-2 omicron variant XBB.1.5 as a proof-of-principle
model.
Specific Aims: Aim 1. Stabilization of SARS-CoV-2 omicron variant mRNA using RNA-plex technology and
develop an LNP mRNA vaccine. Aim 2. Evaluate the efficacy of LNP-RNA-plex vaccine in eliciting immune
responses and protection against SARS-CoV-2 Omicron variant.

Public health relevance
We propose to develop mRNA stabilization technologies to address the thermosensitivity issue of mRNAs, enabling the creation of highly stable and efficient prophylactic vaccines against SARS-CoV-2 omicron variant. Enhanced prevention efficacy of the novel mRNA vaccines can be achieved through optimizing composition and formulation of the RNA-plex technology. The success of this project will significantly simplify mRNA vaccine logistics, widen global access to the vaccines, and booster vaccine performance, not only for COVID-19 but also for a wide range of infectious diseases.